Pathophysiological mechanisms of cannabidiol in stress regulation

PROJECT SUMMARY
Dysregulation in stress responsivity, encompassing mesocorticolimbic and hypothalamus-pituitary-adrenal-axis
pathways, is a psychiatry-transdiagnostic fundamental phenomenon. Current anxiolytic pharmacotherapies are limited
in their efficacy and could cause dependence, low tolerance, and sexual dysfunction. With the growing number of
vulnerable individuals suffering from stress-related disorders in society, there is an urgent need for novel therapeutic
modalities particularly for early intervention and to improve treatments of stress-related disorders. Convergent
evidence from animal and human studies of cannabidiol (CBD), a nonintoxicating and well-tolerated cannabinoid, has
shown to have anxiolytic effects on stress reactivity especially in responses to environmental stimuli (cue-sensitized
states). CBD has multiple pharmacological targets acting as an allosteric modulator of cannabinoid receptors and a
glutamate-modulating agent. Despite recent surges in the use of CBD to alleviate stress symptoms, its
pathophysiological mechanisms in human stress-system pathways remain largely unknown. Understanding the
mechanisms of action of CBD in stress responsivity may lead to novel therapeutic strategies for stress-related
disorders. Based on its safety and the growing evidence of CBD to reduce cue-induced reactivity, we propose to
evaluate the mechanisms underlying CBD’s roles in stress response in a clinical high-risk population of young adults
with early life adversity (ELA), known to exhibit this phenotype. This proposal leverages our clinical and research
expertise with high-risk populations with ELA and our established experience with CBD clinical trials. Specifically, our
neuroimaging study demonstrated prefrontal neuroanatomical impairments associated with enhanced clinical
symptomatology in individuals with ELA. In relation to CBD, we have shown in healthy individuals that oral CBD is
safe and well tolerated. We have demonstrated that CBD reduced cue-induced anxiety in individuals with
psychopathology and that the effects persisted even when the cannabinoid was no longer detectable in the body.
Moreover, in our randomized, double-blind placebo-controlled trial we not only replicated the original findings that
CBD decreased cue-induced anxiety but also showed that it concomitantly reduced physiological stress responsivity
marks (cortisol and heart rate). Importantly, its protracted effects were again evident a week after the last
administration. Notably, our pharmacokinetic trial replicated our previous findings showing rapid bioavailability in oral
CBD dose (400mg) known to have behavioral efficacy. Our hypotheses are that during stress responsivity CBD will:
1) downregulate the neural reactivity in mesocorticolimbic regions; 2) reduce influence of limbic regions within the
stress network dependency hierarchy; 3) reduce neuronal viability in mesocorticolimbic regions; and 4) decrease
endocrine and behavioral hyperreactivity, in clinical high-risk individuals. This study of unmedicated young adult males
and females (N=160) with ELA, will examine neurobiological mechanisms of stress as manipulated by acute CBD vs.
placebo (400mg, oral; using a double-blind, randomized, placebo-control design), as well as determine the
relationship between CBD-sustained (7-day) change and endocrine and behavioral acute stress responsivity.

Public health relevance
PROJECT NARRATIVE Dysregulation in stress responsivity is a growing psychiatry-transdiagnostic fundamental phenomenon, with limited therapeutic strategies. With the legalization of medical and recreational cannabis, many people consume cannabidiol (CBD; a nonintoxicating cannabinoid) to alleviate stress response, without the benefit of scientific guidance. To address this gap, we propose a rigorous translational neuroscience study in a clinical high-risk population to define the roles of CBD in stress response with mechanisms of mesocorticolimbic-network function and hierarchy, neurometabolic, endocrine, and behavior, building upon convergent evidence from animal models and human evidence from our laboratories.